High-performance deep neural networks for medical image analysis

Project Summary
Lack of transparency and trustworthiness of deep neural networks (DNNs) has long been recognized as a major
drawback of the technology, hindering its widespread acceptance in many practical applications. The objective
of this project is to establish a novel contrastive feature analysis (CFA) framework for reliable visualization of the
high dimensional feature space and effective design of high-performance DNNs for medical image analysis. We
hypothesize that CFA-based feature visualization will enable us to quantify the quality of the feature space at
different layers during training/testing of a DNN and empower us with an effective tool to prune the network
architecture for enhanced performance. Specifically, we will (1) develop an efficient visualization technique CFA
for high dimensional feature data, 2) apply the CFA visualization framework to automatically refine DNN
architecture for improved performance, and 3) demonstrate the potential of CFA in solving clinical
problems. Successful completion of the project will enable us to analyze the feature data reliably and quantify
the quality of the feature space at different layers of a DNN. The study also promises to provide high-performance
DNNs for medical image analysis to substantially improve the AI-based diagnosis, prognosis and treatment
planning of different diseases.

Public health relevance
Project Narrative The proposed research is directed at establishing a novel strategy of analyzing the feature space data extracted from medial images by deep neural networks (DNNs). Successful completion of the project will enable us to analyze the feature data reliably and quantify the quality of the feature space at different layers of a DNN. The study also promises to provide high-performance DNNs for medical image analysis to substantially improve the AI-based diagnosis, prognosis, and treatment of different diseases.